Diversity Supplement: Determinants of Hsp90-client interaction

Project Abstract The highly conserved abundant molecular chaperone Hsp90 is a global cellular regulator that interacts with client proteins in a dynamic ATP-dependent cycle to ensure client protein folding, transport and/or assembly into multiprotein complexes. Hsp90- dependent proteins have critical roles in many forms of cancer and neurodegenerative disease as well as cystic fibrosis and other diseases. Our long-term goal is to understand how Hsp90 and cochaperones cooperate in the folding of hundreds of proteins with diverse sequences and structures sufficiently to develop small compounds that only affect subsets of Hsp90 clients. In the first Aim, we will use a novel set of Hsp90 mutants to understand how three cochaperones that bind the closed, ATP and client-bound conformation of Hsp90 fine-tune client folding. The second Aim will identify and characterize Hsp90 mutants that affect different subsets of client proteins. Together these studies will enable a better mechanistic understanding of the function of cochaperones in regulating client selection, conformation and activity. Identification of clusters of Hsp90 mutants with similar effects will pave a path towards rational design of compounds with selective effects on Hsp90 clients in vivo.

Public health relevance
PROJECT NARRATIVE: The Hsp90 molecular chaperone assists the folding of many cellular proteins, including those that help drive cancerous growth. Hsp90 inhibitors are effective against cancer, but current inhibitors are too toxic. This project will lead to new strategies to selectively alter Hsp90 function, thereby disrupting its role in cancer progression and other diseases while reducing toxicity due to inhibition of other critical functions.